GENETIC EPIDEMIOLOGY OF BLOOD PRESSURE TO DIURETICS

The overall objective of this research is to determine whether measured variation in four loci in each of five genes coding for components of the renin-angiotensin-aldosterone (RAA) system predicts interindividual differences in blood pressure response to diuretic therapy in 300 hypertensive African Americans and in 300 hypertensive non-Hispanic whites.